Advanced Workshop on Research Skills in Oncology

PROJECT SUMMARY
Background: We propose to continue a successful three-day virtual workshop on cancer research skills for
early-career PIs, which we developed as part of the NCI Awardee Skills Development Consortium (UE5
CA246746). The workshop aims to address worrisome declines in the size and retention of the early-career
research workforce by providing training to improve performance and sustainability, grounded in the Job
Demands-Resources Model. The need for this training is clearly demonstrated by the overwhelming demand
for the workshop (three times as many applications as spots), and we observed significant improvements in
targeted skills at 6 months. Based on feedback from all participants and pre-course skills assessments, we
plan to enhance the workshop by including additional content in the form of two elective tracks tailored to
different needs across research areas. Early-career clinical and supportive oncology PIs have a greater need
for additional training in advanced research methods and early-career basic science and translational PIs have
a greater need for training in management skills. Adding elective tracks will allow for targeted content based on
needs, greater contextualization, and increased opportunities for potential collaborations among participants.
Approach and setting: Over the course of five years, we will train 180 early-career PIs with eligible grants in
oncology research. The proposed workshop targets three skill areas that we believe will contribute to long-
term, productive research careers in oncology: 1) advanced research methods to successfully complete funded
studies and grow programs of research in oncology; 2) leadership skills drawn from the Dana-Farber Cancer
for early career faculty; and 3) resiliency skills using the framework of
Acceptance and Commitment Therapy (ACT). The clinical and supportive oncology elective track will include
recruiting strategies, managing multi-site studies, and building multi-disciplinary teams. The cancer research
management elective track will include training on the financial management of labs, communication with
teams, and managing challenging personnel. The Dana-Farber Cancer Institute (DFCI) will host this three-day
workshop on Zoom in collaboration with Massachusetts General Hospital (MGH), another Dana-
Farber/Harvard Cancer Center (DFHCC) institution. Each day of the workshop, participants attend interactive
didactic sessions and meet in small discussion-based groups with coaching from R01-funded investigators in
oncology. We will work with the Harvard Center for Palliative Care on the promotion, production, and
evaluation of workshop. Faculty: We have assembled an outstanding team of experts in oncology research
training (established independent researchers, grant reviewers, and journal editors) to continue to serve as
workshop faculty. As leaders of highly-productive and well-known programs at DFCI and MGH, the PIs (Drs.
Pirl and Greer) possess the requisite experience and leadership skills to organize this workshop.

Public health relevance
PROJECT NARRATIVE We propose to continue a successful three-day virtual workshop on research skills for early-career PIs to address observed decreases in the early-career cancer research workforce. The workshop will teach advanced research methods, leadership skills, and professional resiliency, with two elective tracks to meet diverse needs.